CAFFEINE IN DIAZOXIDE INDUCED RENIN RELEASE IN BETA-BLOCKED NORMAL SUBJECTS

To determine whether caffeine effects renin release indirectly via increased sympathetic activity or directly within the kidney.